International Brotherhood of Teamsters Hazardous Materials Worker Health and Safety Training

Principal Investigator/Program Director (Last, First, Middle): Byrd, Lamont FOA Number RFA-ES-19-003
Program Summary/Abstract (Overall)
Project Title: International Brotherhood of Teamsters Hazardous Materials
Worker Health and Safety Training
Application Organization Name: International Brotherhood of Teamsters
Address: 25 Louisiana Avenue, NW Washington, DC 20001
Project Director Name: Lamont Byrd
Contact Phone Number: 202-624-6960
Email Address: [email]
Website: teamsterworkertrainingprogram.org
Grant Program Funds Requested: $12,953,953
The International Brotherhood of Teamsters (IBT) Consortium is applying for funding under the
Hazardous Waste Worker Training (HWWTP), Environmental Worker Training Program
(ECWTP), and the Hazardous Disaster Preparedness Training (HDPTP) cooperative agreements to
provide appropriate model health and safety training. The targeted population for the HWWTP is
workers who are engaged in hazardous waste remediation, hazardous materials transportation,
warehousing, solid waste and recycling, airline, and emergency response. The ECWTP will target
members of disadvantaged and underserved communities to provide them with the life skills and
job training needed to obtain employment and pursue environmental career paths. The HDPTP will
target workers and community members who work and live in disaster prone areas and are likely to
be involved in response and recovery activities.
The long term objectives and specific aims of the IBT Consortium are to increase worker,
community, and environmental safety and resilience by training workers to appropriately respond
to accidental releases of hazardous materials, work safely on hazardous waste remediation projects,
safely transport hazardous materials via truck, rail, or air, and safely respond to natural disasters.
The IBT Consortium will access the nationwide population of targeted workers through
established partnerships with appropriate partners to deliver training to 15,745 workers in the
HWWTP, 730 workers in the ECWTP, and 4,455 workers in the HDPTP, for a total of 20,930
workers trained during the 5-year project period.
IBT Consortium Page 1 Program Summary/Abstract (Overall)

Public health relevance
Principal Investigator/Program Director (Last, First, Middle): Byrd, Lamont FOA Number RFA-ES-19-003 Project Narrative (Overall) The IBT Consortium represents and has ready access to tens of thousands of workers throughout the U.S. who remediate hazardous waste sites, transport hazardous wastes, handle, package, transport and warehouse hazardous materials, and respond to hazardous materials releases. The IBT Consortium is staffed by a team of experienced worker health and safety training experts who specialize in industrial hygiene, curriculum development, adult education techniques, information technology, and craft-experienced worker-trainers. The combination of access to worker populations and institutional capacities enables the IBT Consortium to deliver high quality model training that complies with the NIEHS Minimum Criteria, applicable standards and regulations as promulgated by the Environmental Protection Agency (EPA), Occupational Safety and Health Administration (OSHA), and the Department of Homeland Security (DHS). IBT Consortium Page 1 Project Narrative (Overall)